Fluorescence Lifetime Imaging/Spectroscopy System For Robotic Cancer Surgery Guidance

PROJECT SUMMARY
In this competitive renewal for R01 CA187427, we will continue to advance label-free Fluorescence Lifetime
Imaging (FLIm) to enhance the functionality of the widely-used da Vinci Surgical platform with an emphasis on
Trans-Oral-Robotic-Surgery (TORS). UC Davis has pioneered the intra-operative use of FLIm and our partner,
Intuitive Surgical, is the global leader in robotic-assisted surgery. To date, we have demonstrated a) the
synergetic integration of a point-scanning FLIm device with the da Vinci Surgical System (first-of-its-kind); b) the
potential of this approach to improve surgical decision-making during TORS without modifying conventional
clinical protocols; and c) the utility of FLIM-derived parameters detecting biochemical and metabolic
characteristics to distinguish oral and oropharyngeal cancer in real-time from surrounding normal tissue in
patients in-situ.. We also developed innovative methods for real-time dynamic augmentation of imaging
parameters on the surgical field of view. Capitalizing on the major accomplishments and knowledge gained under
the current R01, the overarching objective of this renewal application is to 1) demonstrate FLIm’s diagnostic
value in prospective studies by accounting for biological/experimental variables identified as critical under the
current R01 and leveraging pre-operative imaging and clinical information and 2) enhance the visualization of
FLIm-based classifiers on the surgeon console for real-time intraoperative feedback. To accomplish our overall
objective, we propose three specific aims: Aim 1. Expand the FLIm database and develop tissue-type classifiers
(retrospective analysis) accounting for biological variables (e.g., patient age/sex, tumor origin/location) and
experimental situations (e.g., epithelial surface vs deep margins, tumors of an unknown primary) and the pre-
operative imaging (CT, PET) features used in surgical planning. Aim 2. Develop, validate and perform regulatory
activities for enhanced FLIm data visualization in support of prospective clinical studies. Aim 3. Validate FLIm as
a means of real-time intraoperative TORS guidance in a prospective study analysis.
In summary, this study will demonstrate the clinical feasibility and utility of FLIm for intraoperative real-time
assessment of oral and oropharyngeal cancer surgical margins. The acquired FLIm parameter database will
enable subsequent large clinical trials for automated tissue classification and diagnostic prediction. While the
focus of this application is on TORS surgeries, the label-free FLIm-based tissue assessment, characterized by
simple, fast and flexible data acquisition and display, can be broadly applied to other procedures as the da Vinci
Surgical System is used in a wide range of tumor surgeries including urologic, colorectal, gynecologic, and
thoracic cancers.

Public health relevance
PROJECT NARRATIVE Optimal cancer and functional outcomes from surgical treatment of head and neck cancer requires the surgeon to have the ability to intraoperatively distinguish neoplastic disease from adjacent normal tissue. Our novel optical imaging FLIm technique, coupled to the da Vinci surgical system, captures and analyzes tissue autofluorescence to identify distinct tissue types and display this information onto the surgeon’s field of view during trans-oral- robotic surgery (TORS). This enables a more accurate and optimal cancer removal while preserving adjacent normal tissue and function. The successful validation of FLIm, with the sophisticated incorporation of head and neck cancer patient and radiology data to improve the tissue classifier, will allow for more cures with less long- term side effects and will be easily extended to other robotic and endoscopic procedures, thus advancing innovation well beyond TORS.